Research Capacity Core

RESEARCH CAPACITY CORE – ABSTRACT
The NYC-MEHSJ Research Capacity Core (RCC) will strengthen the productivity of the research projects, the
quality of pilot projects, and the overall research capabilities of faculty scholars and researchers at the City
College of New York (CCNY). Recurring emphasis will be on research that can potentially eliminate or reduce
health disparities (HD). Conceptual prowess and practical familiarity with relevant research and analytical
techniques are critical to research excellence and productivity; therefore, this core will focus on equipping and
supporting our investigators with technical resources and cognitive skills through technology workshops, hands-
on training, team-building initiatives to encourage collaborative efforts, and optimized access to research
equipment and resources currently scattered across the campus. Led by a team of senior researchers from
diverse disciplines, the capacity-building resources and services administered through this core will be organized
under four interwoven themes. The Research Technology Resource will mobilize critical research cores and
instrumentation operations across campus to create a coordinated research infrastructure network accessible to
Center investigators and campus researchers at large. Hands-on training in the concepts and applications of
cutting-edge equipment and techniques will be provided to strengthen researcher capabilities in conceiving,
designing, conducting, and analyzing innovative and HD-related research at the cutting edge of their fields. The
Research Design and Analytics Resource will deploy a full-time doctoral-level professional as well as
biostatisticians and bioinformaticists to provide CCNY with expert consultations in rigorous research design and
hands-on data analytics across scientific disciplines. We will establish a service that includes hardware and staff
support in data structures, data warehousing, data analytics, and communications tools consistent with NIH’s
ongoing emphasis on research rigor and reproducibility. The Research Artificial Intelligence (AI) Resource
will build on the reality that AI tools and concepts are defining the next frontiers of research and innovation across
disciplines, whereas significant challenges related to HD persist. We will develop and deploy data tools, learning
algorithms, and devices for detecting and debiasing AI systems, particularly those used in biomedical,
behavioral, and clinical HD-related research. Core tools developed or acquired, from EHR to diagnostic and
language tools, will be available to our researchers, along with training to deploy them in their research. The
Community Participation Resource will work intimately with the Community Engagement Core and with
investigators to implement proven strategies for engaging served communities in research co-ideation,
community participation in ongoing research, strategizing to improve access to healthcare-related technologies,
and provide communication support for our investigators whose research involves access to clinical or
community-drawn participants. We expect these resources and services to strengthen the proposed research
projects and the anticipated pilot projects and raise the overall HD research quality and productivity at CCNY.

Public health relevance
Per Funding Opportunity Announcement (FOA) Number RFA-MD-24-001 Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.